Using the Ultrastable Cyclotide Scaffold to Modulate Protein-protein Interactions

Project Summary Not required for this Administrative Supplement submission.

Public health relevance
Project Narrative Not required for this Administrative Supplement submission.